NIH Common Fund Replication Prize

The “Replication Prize” is a prize competition of the Common Fund of the National Institutes of Health (NIH) that seeks to advance scientific research by collecting ideas and strategies to make important lines of biomedical research more replicable. This is a two-track federal challenge and is being conducted under the America Creating Opportunities to Meaningfully Promote Excellence in Technology, Education, and Science (COMPETES) Reauthorization Act of 2010, as amended [15 U.S.C. § 3719]. The Replication Prize will crowdsource ideas to identify high impact areas of science for future replication efforts and to reward efforts in increasing replicability in important areas of biomedical research. The goal of this prize competition is to boost current replication efforts and encourage a culture change in biomedical research where replication activities are a routine part of conducting research.
Submissions will address at least one of two tracks:
• Track One (Replication Ideas): Submissions will identify high impact areas of research that are in need of replication studies.
• Track Two (Replication Exemplars): Submissions will highlight the strategies used to integrate replication into ongoing research activities. The winning strategies will be compiled as a publicly available reference.